Modulating prefrontal circuits underlying behavioral flexibility in OCD: a TMS study

PROJECT SUMMARY/ABSTRACT
The primary goal of this proposed COBRE Center for Neuromodulation Project is to elucidate neural circuits
underlying impairments in behavioral flexibility in OCD, using transcranial magnetic stimulation as a probe of
the system and fMRI to measure functional changes within neural circuitry implicated in behavioral (in)flexibility
in obsessive-compulsive disorder (OCD). OCD is a chronic and impairing neuropsychiatric disorders
associated with impairments in behavioral flexibility – most notably, the compulsions which are a hallmark of
the disorder. Patients with OCD also show impaired behavioral flexibility on a range of experimental tasks
(e.g., set-shifting, task-switching, reversal learning). Moreover, neuroimaging findings in OCD routinely show
abnormal patterns of activation during tasks probing behavioral flexibility. The proposed research project will
use slow frequency (1-Hz) rTMS to probe dysfunctional circuitry, targeting frontal pole, an area involved in
higher level cognitive control processes which likely plays a key role in coordination between multiple neural
circuits involved in behavioral flexibility and which shares structural and functional connections to circuitry
implicated in behavioral inflexibility in OCD. We aim to test whether (1) slow frequency (1-Hz) rTMS to frontal
pole can affect functional changes within circuits showing abnormal functioning during behavioral flexibility in
OCD, (2) whether rTMS targeting this circuitry can affect behavioral changes in a population with deficits in
behavioral flexibility, and (3) whether circuit functioning relates to behavioral performance following rTMS.
While a number of studies have shown abnormal neural circuit functioning during behavioral flexibility tasks in
OCD, to our knowledge, this will be the first to move beyond correlational findings to directly examine changes
to circuit functioning following a probe of the system using TMS. The long-term goal of this work is to inform
target identification for development of neurocircuit-based interventions which may improve treatment
outcomes for those with OCD.

Public health relevance
PROJECT NARRATIVE Obsessive-compulsive disorder is a chronic and impairing neuropsychiatric disorder which affects 1-3% of the population and is marked by difficulties with behavioral flexibility. This project will aim to better understand the brain circuits underlying these difficulties. The long-term goal of this work is to identify targets for development of new brain-based treatments to improve behavioral flexibility for those with OCD.